Vital Testing Core

PROJECT SUMMARY - CORE 002 VIRAL TESTING
Rigorous and repeatable pathogen detection testing is required for maintenance and expansion of SPF macaque
colonies. The WaNPRC Pathogen Detection Services Laboratory (PDSL) has provided testing services since
the inception of non-human primate (NHP) SPF colonies in the mid-1980’s and the animals have contributed
significantly to advances in disease research including AIDS therapies, vaccines and hundreds of research
projects. We propose to continue this high-quality testing for SPF agents, to improve the assays and to expand
on the agents to be detected for purposes of animal health, human safety and research enhancement.